Vangl2 function in mammalian convergent extension

? DESCRIPTION (provided by applicant): Elongation of the body in the head-to-rump axis is a fundamental aspect of vertebrate embryogenesis whose failure is associated with neural tube defects and embryonic mortality in fish, frogs, mice, and humans. In humans, neural-tube defects affect 1 to 2 infants per 1000 births and lead in the worst cases to early infant mortality and in less severe cases to lifelong medical treatment and disability. Elongation occurs by a process in which cells of the future spinal cord and associated mesoderm actively move (intercalate) between one another to form narrower, longer tissues (called convergence and extension' or CE), which elongates the embryonic body. In vertebrates, this mediolateral cell intercalation is dependent on the non-canonical Wnt planar cell polarity (Wnt/PCP) pathway, which consists of a core set of proteins thought to polarize cells within the plane of the tissue: the membrane proteins Celsr, Frizzled (Frz), and Van Gogh-like (Vangl), and the intracellular proteins Dishevelled (Dvl) and Prickle (Pk). Mice carrying mutations in the genes Celsr1, Frz3/6, Vangl2 and Dvl1/2 as well as Ptk7 and Scrib, two genes not directly associated with Wnt/PCP, exhibit a characteristic phenotype of a short, wide body axis, an open neural tube, and lethality at birth. One model of genetic regulation of cell intercalation focuses on polarized remodeling of junctions at the apical surfaces of epithelial cells and the other on polarized crawling of non-epithelial cells. Use of high resolution, multi-plane time-lapse confocal microscopy to simultaneously image both apical junctional and the basolateral surfaces of the neural epithelium of normal mouse embryos as compared to Vangl2 and Ptk7 mutants, showed that apical cell boundary rearrangement and polarized basolateral protrusive activity must act cooperatively for mediolateral intercalation and CE to occur. Neural cells lacking Ptk7 fail to planarly polarize both apical and basolateral cell behaviors and they intercalate vigorously but randomly. Surprisingly, polarity of both basal protrusive activity and apical boundary rearrangement is maintained in the Vangl2 mutant, and instead the frequency of apical neighbor exchange is significantly diminished. These unexpected observations, and other, published variations in phenotypes of Wnt/PCP mutant genes across the chordates, suggest that Wnt/PCP function has diversified across species and tissues. The proposed experiments explore this possibility by determining how Vangl and the related protein Scrib regulate neural cell behavior. First, because the loss of Vangl2 does not affect planar polarity of cell behavior, we will test whether the paralog Vangl1 can compensate to generate polarity in the absence of Vangl2, or whether polarity is regulated instead by a complex of Vangl2 and Scrib. Second, because Vangl2 specifically affects apical junctional rearrangement, we will test whether it affects the dynamics of cadherin-based adhesion in neural cell intercalation. The results will provide broader and deeper insights into the cellular behaviors regulated by the Wnt/PCP pathway during neural development, and how they coordinate elongation and closure of the neural tube.

Public health relevance
PUBLIC HEALTH RELEVANCE: During its development the mammalian embryo must undergo a process of lengthening and narrowing, changing from a spherical shape to an elongate one with the head at one end and the tail at the other. This process drives the formation of the spinal cord and the associated vertebral skeleton and ribs. How this occurs is not well understood, and when it fails it results in significant birth defects in the fetus. The wok proposed here will contribute to a better understanding of the normal process, and of the critical elements affected in cases of neural tube defects.